Biophysical Control of Cell Form and Function by Single Actomyosin Stress Fibers

PROJECT SUMMARY/ABSTRACT
Actomyosin stress fibers (SFs) enable cells to tense the extracellular matrix (ECM), a process key to cell shape
determination, motility, and morphogenesis. Over the past 15+ years, including the past period of R01
support, we have made significant contributions to the field’s understanding of SF mechanics and contributions
to cell structure. Our work is particularly notable for the use of femtosecond laser nanosurgery (FLN), which
has enabled us to show that the three canonical SF subtypes – dorsal fibers, transverse arcs, and ventral
fibers – collectively enforce a front-back tension gradient that underlies two-dimensional (2D) mesenchymal
migration. We also showed that the SF network architecture can mechanically reinforce individual SFs, which
has significant implications for symmetry breakage during directed migration and force propagation through cell
monolayers. With this intellectual foundation in place, our renewal application turns to two important
questions: How is polarization of tension in the SF network encoded by molecular signals classically
understood to establish front-back polarity? And how does our knowledge of 2D SF networks translate to
confined migration geometries like those found in tissue? We will address these questions through two
specific aims, both of which build upon publications from this award. In Specific Aim 1, we will investigate
mechanistic contributions of cofilin-1 to establishment and maintenance of SF front-back tension polarization
during migration. We hypothesize that cofilin-1 establishes front-back polarization of SF tension by promoting
the assembly and contractile maturation of transverse arcs. By combining biophysical, engineering, and cell
biological tools, we will identify key molecular and force-based signals that modulate recruitment of cofilin-1 to
developing transverse arcs. In an innovative new collaboration with Dr. Bruce Goode (Brandeis) we will
reconstitute actin bundles in microfluidic devices and quantify the relationship between tensile force and cofilin-
1 engagement. In Specific Aim 2, we will dissect contributions of SF networks to migration in confined
geometries where the ECM imposes axial cues and sterically precludes elaboration of 2D SF networks. We
hypothesize that increasing confinement redirects SF assembly from the 2D dorsal fiber-transverse arc-ventral
fiber assembly pathway towards de novo parallelized SF assembly. We will combine microengineered culture
platforms, single-cell mechanical tools, and superresolution imaging to probe confinement-induced changes in
SF assembly, architecture, and mechanics. Aim 2 will leverage two established, productive collaborations:
With Dr. Ulrich Schwarz (U. Heidelberg), we will develop multiscale computational models that relate SF
network architecture and mechanics to cell migration in confined spaces. With neurosurgeon Dr. Manish Aghi
(UCSF), we will test the clinical value of our observations by asking if confined migration of glioblastoma stem
cells is retrospectively predictive of in vivo invasion patterns. Our studies will create unprecedented new insight
into how SFs contribute to migration, with innovative methodology and close connection to human disease.

Public health relevance
PROJECT NARRATIVE The ability of cells to define, change shape depends on their ability to mechanically tense their surroundings through actomyosin-based stress fibers (SFs). In this proposal we combine single-cell tools, traditional cell and molecular biological approaches, and tissue-mimetic culture platforms to investigate how individual SFs with a cell contribute to tension and motility relevant to brain cancer.